Dissecting the Conformational Flexibility of HIV-1 Envelope Glycoproteins

ABSTRACT
HIV-1 envelope glycoproteins (Envs) mediate viral entry into host cells and are the sole target of neutralizing
antibodies. HIV-1 Envs of most primary HIV-1 strains typically exist in a closed conformation (State 1) and
occasionally transit to downstream, more open conformations (State 2 and State 3). Thus, current knowledge
guides immunogen design towards mimicking the Env closed conformation as the preferred target for eliciting
broadly neutralizing antibodies (bnAbs) to block HIV-1 entry. However, Env preferred conformations of more
than 37 million different circulating HIV-1 strains are unlikely to adopt exactly the same closed conformation. And
we still do not know how different State 1 conformations of diverse natural HIV-1 variants are.
Our hypothesis: State 1 Envs form a heterogenous group of Envs that exist in similar but not identical
conformations. Accordingly, improved ability of bnAbs to recognize multiple Env conformations will
broaden their neutralization activity.
To test our hypothesis, we will assess the conformational heterogeneity of Envs from different strains and build
mechanistic models for 1) Envs transitions, 2) generation and transmission of Envs that exist in specific
conformations, and 3) broad recognition of different Env states. In Specific Aim 1 we will study the conformational
diversity of transmitted/founder (T/F) HIV-1 strains, which can establish HIV-1 in vivo and are the only target of
a preventive vaccine. We will study the mechanisms by which T/F Envs expose internal elements and how they
transit to downstream conformations. In Specific Aim 2 we will investigate the generation and evolution of
incompletely closed Env conformation. We will reconstruct the evolution pathway of T/Fs in patients by using
available viral sequences to build evolved viruses at different time point followed by investigating changes in
their conformational states over time. In parallel, we will study Env conformational diversity among HIV-1 strains
that are archived in the latent HIV-1 reservoir of people living with HIV-1 and identify potential targets for
therapeutic interventions. These approaches will allow us to build a mechanistic model for how incompletely
closed Envs are generated, evolved, and transmitted. In Specific Aim 3 we will define important parameters for
broad recognition of CD4-binding site (CD4-bs) on different Env conformations of diverse primary strains. We
will study how the exceptionally broad N6 (CD4-bs) bnAb recognizes different Env conformations, will identify
critical interactions with residues on open and closed Env conformations, and will solve cryo-EM structures of
HIV-1 Envs in complex with N6 to define the mechanism of broad recognition.
Overall, our study will provide high-resolution and comprehensive view on the biology of HIV-1 entry pathway,
will refine the knowledge on HIV-1 Env conformations, and will form a strong basis for the development of new
strategies for HIV-1 cure and vaccine design.

Public health relevance
NARRATIVE Changing the course of the HIV-1 pandemic requires an effective HIV-1 vaccine that most probably will have to elicit antibodies against HIV-1 envelope glycoproteins (Envs). Here we will study differences and similarities in the shape of Envs from different HIV-1 strains and build a mechanistic model for how these differences evolve and generated in vivo, and what is required to recognize the diverse shapes of HIV-1 Envs. Our study will provide insights into the biology of HIV-1 entry and lay a new groupwork for understanding HIV Env function & inhibition.